Development of Nanomedicines for Tuberculosis Treatment

Project Summary: Sub-Saharan Africa, in particular South Africa is disproportionately challenged by a burden of deadly infectious diseases including tuberculosis (TB). South Africa has the highest burden of TB in the world (22.5% of the global burden). Furthermore, TB that is resistant to existing drugs is on the rise. However, there are very few new drugs for TB in the drug discovery pipeline. Further, it is not encouraging to note that in the current era of increasing antimicrobial resistance, new drugs are faced with a real threat of pathogen resistance emerging soon after clinical use; as was recently observed with bedaquiline, whereby resistance was detected 2 years after clinical use. The combination of increasing multidrug resistance, global population density and international travel urgently calls for the development of novel therapeutics for TB. Under this 5-year mentored K43 award, I intend to investigate a new treatment modality that employs nanoparticles to activate the innate immune system for treatment of TB (immuno-therapy). As a Postdoctoral fellow in nanomedicine at the University at Buffalo, we synthesized nanoparticles functionalized with an immune modulating ligand (β-glucan), and demonstrated that these nanoparticles could stimulate the TB host cells, i.e. macrophages, to produce cytokines and oxidative species known to be critical to the eradication of the TB causative organism Mycobacterium tuberculosis (M.tb). Under this award, I will determine whether this cellular response leads to death of M.tb in macrophages and mice. This study will generate proof of concept data towards the development of this new treatment modality. My prior training in nanomedicine was focused on the synthesis of nanoparticles and how to characterize them. However, my career objective is to be a leader in the development of nanomedicines for the treatment of infectious diseases. Therefore, I intend to undergo extensive training in the biology and immunology of infectious diseases and pharmacokinetics, and to also improve my research leadership skills. I will gain these skills through completing didactic and hands-on training courses and group learning. I believe these additional skills will complement my current skills (in nanoparticle synthesis), to equip me to rationally design nanomedicines and effectively collaborate with infectious disease medical experts throughout my career. My mentorship team comprises established researchers in TB biology and immunology and nanotechnology (South Africa mentors) and drug development (US mentor). I will leverage the scarce resources such as biosafety level 3 facilities as well as the excellent teaching and research environment at institutions in South Africa and the US, to successfully complete my training and research goals.

Public health relevance
Project narrative: The overall goal of this project is to provide advanced training to equip Dr. Admire Dube (a scientist in nanotechnology) with skills and competencies in the biology and immunology of infectious diseases. These skills will equip Dr. Dube to establish a research career in the development of nanomedicines for the treatment of infectious diseases. The burden of infectious diseases is a global concern, particularly in Africa where Dr. Dube is resident.